Supplement to: Medication Development for the Treatment of Alcohol Use Disorder - U01AA028957

Nearly 15 million people in the US and ~100 million worldwide suffer from AUD. Over 5% of all medical
morbidities share an ethanol-related risk. Although there are three FDA approved drugs to treat AUD, and
several others are used off-label, medications have shown only modest success (in ~20% of patients
treated). As a consequence, there is an urgent need for new pharmacotherapeutics across the DSM-V
AUD spectrum. Our approach in U01AA028957 was a straightforward medchem plan, IND-enabling
studies followed by first in human safety tests. A supplement is requested to meet unexpected direct
expenses for Original Aim 1 and 2 with benefit to aims 3-4. [Original Aims: 1: Development of
manufacturing standards; 2: Completion of pre-clinical IND enabling studies; 3: Phase I clinical trial; single-
ascending dose; 4: Phase I clinical trial; multiple-ascending dose.] Specifically, based on estimations from
Charles Rivers Lab and our consultants, we had anticipated needing 1 kg of compound to complete the
animal studies of aim 2. As such, the purification method we developed would have sufficed. However,
we now need to significantly upscale production. Curia Global is a company that produces metric tons of
minocycline and has competitively bid to complete the GMP drug needs for this grant. However, we need
them to eliminate a purification step, which, if successful, will dramatically reduce the future costs of the
higher need. Given their experience with tetracycline and in further discussions with them, they are
confident they can remove the problematic chromatographic purification step during tech transfer. The
dividend for Aims 3 and 4 will be that the commensurate costs will be ~$16,000 rather than ~$60,000 per
kg. These costs were not covered in the original proposal. The goal of the supplement is: To improve
efficiency and increase output from 1 to approximately 15 kg butylether minocycline in support of both
pre-IND and phase 1 activities.

Public health relevance
Public Health Relevance Statement (Project Narrative) Alcohol Use Disorder is a complex spectrum disorder that presents significant unmet clinical treatment challenges. Accumulating evidence indicates that the action of ethanol on the innate immune system leads to chronification of risky drinking, potential physical dependence, and often dangerous withdrawal symptoms. The proposed project is a collaboration with NIAAA’s Division of Medications Development and addresses creation of manufacturing standards for a lead compound needed for IND-enabling studies for FDA approval for a Phase I clinical trial.